Food and Light Cue Entrainment of the Ovulation Stimulating HPG Axis

Abstract
Circadian disruptions like shift work are associated with reproductive health difficulties including infertility. When
estrogen is high, the circadian system triggers the pre-ovulatory luteinizing hormone (LH) surge at lights-off in
humans and rodents. These rhythms are perturbed, however, when food is eaten during the rest phase, as is
common in shift work. In rodents, mistimed food reduces fertility by 30% and disrupts the normal timing of mating
behavior and ovulation, but the mechanisms are not known. We will test the hypothesis that misalignment of light
and food cues compromise the function of kisspeptin neurons of the anteroventral periventricular nucleus
(AVPVKISS) and prevent the normal timing of the LH surge. First, in Aim 1, we will map AVPVKISS monosynaptic
projections for the first time with a paired adeno associated virus and G-deleted rabies virus in Kiss1Cre mice.
We have confirmed that AVPVKISS afferent neurons are located in areas that include the suprachiasmatic nucleus
(site of the central circadian clock) and the arcuate nucleus (key area in feeding regulation). By mapping this
circuit, it will give us insight into regions important for the induction of the LH surge and will provide our lab and
the field with new mechanistic targets. In Aim 2, we will investigate whether food-sensitive arcuate AgRP and
POMC neurons link mistimed food to the desynchronized LH surges. These cell groups are complementary
orexigenic and anorexigenic neurons that project to the AVPV, and the AgRP cells have previously been shown
to encode food timing. We will test the effect of silencing these neurons specifically during conditions of food
restriction with the prediction that this will relieve the pressure of mis-timed food and rescue the normal
synchronized LH surge time. Together, these experiments will establish candidate inputs to the regulation of
ovulation and establish the role for food sensitive neurons in transducing food intake rhythms to rhythmic
physiology and behavior. This research project provides an opportunity for learning the theory and techniques of
modern systems neuroscience through the lens of reproductive neuroendocrinology. The proposed experiments
will provide fundamental training in neural reproductive research and enable the study of circadian control of
other neuroendocrine signaling systems in the future. Further career development training will include writing
and reviewing manuscripts, didactic coursework, pedagogy and mentoring training, and opportunities to present
the results and network at OHSU symposia and at national meetings. The training will take place in the
Neuroscience Graduate Program's collaborative and supportive environment within the Vollum Institute at
OHSU.

Public health relevance
Project Narrative Mating behavior and ovulation are normally tightly regulated by the ~24h circadian clock and synchronized to the light-dark cycle. My proposed research aims to identify the mechanisms that explain how mistimed food—a common aspect of shift work with caloric intake during the normal rest period—impairs fertility and disrupts daily patterns of ovulation. I will map the monosynaptic inputs to kisspeptin cells that stimulate the preovulatory luteinizing hormone surge, and then test the hypothesis that blocking input from metabolic- and appetite-related neurons can prevent the reproductive detriments caused by mistimed food.